Systems Biology of Kidney Disease

DESCRIPTION (provided by applicant): The International Society of Nephrology (ISN) is dedicated to advancing the diagnosis, treatment, and prevention of kidney diseases in the developing and developed world. This meeting helps bring together leading nephrologists and active investigators in the area of systems biology of renal disease for 4 highly interactive days. We are requesting funds to assist in subsidizing airfare, registration and accommodations for 15 junior investigators. PUBLIC HEALTH RELEVANCE: The International Society of Nephrology (ISN) is dedicated to advancing the diagnosis, treatment, and prevention of kidney diseases in the developing and developed world. This meeting helps bring together leading nephrologists and active investigators for 4 highly interactive days.

Public health relevance
The International Society of Nephrology (ISN) is dedicated to advancing the diagnosis, treatment, and prevention of kidney diseases in the developing and developed world. This meeting helps bring together leading nephrologists and active investigators for 4 highly interactive days.